CE25-026 - Evaluating Comprehensive Child Sexual Abuse Prevention Initiatives: A Cluster Randomized Trial of Rural Elementary Schools

Project Summary/Abstract
Child sexual abuse (CSA) is a significant, preventable major public health issue associated
with considerable adverse physical and mental health outcomes. Notably, CSA is typically
committed by someone the child knows and trusts (CDC, 2024; Finkelhor & Shattuck, 2012),
and a significant portion of sexual harm involves problematic sexual behavior (PSB) of youth
(Gewirtz-Meydan & Finkelhor, 2020). Schools are on the frontline for preventing CSA and PSB
of youth. Rural schools are particularly vulnerable to the impact of CSA due to health disparities,
low-resourced areas, and stigma (Morales et al., 2020). Consistent with recommendations of
prevention leaders, Praesidium is a widely disseminated CSA and PSB prevention program
designed to comprehensively address policies and procedures that shift the organizational
culture to one of protection and child well-being. Program evaluations are promising, but
rigorous evaluation has not yet been implemented. Directly teaching rules about boundaries and
sexual behavior is critical to prevention of PSB. Both the ROAR and Stop-Go-Tell prevention
programs have been successfully implemented in numerous schools; report positive feedback
from caregivers, students, and school personnel; and have considerable demand for the
program in the state. The present study is a cluster randomized trial designed to rigorously
examine a comprehensive multi-layered approach to address prevention at the organization,
professional, caregiver, and student levels (Praesidium with ROAR and Stop-Go-Tell integrated
as consumer participation tools). Forty rural elementary schools that meet inclusion criteria will
be randomized to the intervention or waitlist control condition. Integration of consumer
(caregiver, youth, school personnel, and partner agencies) authentic voices comprehensively
during the planning year and throughout the implementation and dissemination of the project is
designed to enhance program and research quality, engagement, and reduce attrition. Further,
strategies to enhance impact and sustainability through repetition, self-analysis, and train-the-
trainer implementation will be tested. Qualitative methods will be utilized to examine contextual
factors impacting school culture, implementation fidelity, facilitators, barriers, costs, and
unintended consequences. Oklahoma is prime to conduct this research as it builds on our
longstanding collaborative partnership among key leaders, investment of the state and
community in CSA and PSB prevention, and commitment to our rural communities. Results will
have important implications for prevention services to youth in underserved, diverse rural
communities that is currently a critical gap in the CSA and PSB prevention literature.

Public health relevance
Project Narrative Primary and secondary schools are in the unique position to not only implement strategies to prevent child sexual abuse (CSA) but also to directly address problematic sexual behavior (PSB) of youth. Little research has rigorously evaluated system-wide standards in programs designed to combat CSA and PSB in school settings. This project aims to approach primary prevention of CSA and PSB through a multilayered approach addressing school-wide policy, procedures, and training to shift school-wide organizational culture to embrace responsibility of student safety from CSA and PSB and integrating direct teaching to support knowledge and practice of CSA and PSB prevention skills in the classroom.